Antibiofilm/Antimicrobial Combination for Infections Associated with Vascular Cat

DESCRIPTION (provided by applicant): Infections associated with indwelling medical devices, particularly catheters account for about half of nosocomial infections in the United States. These infections prolong hospital stay and result in substantial morbidity and mortality. Bacterial colonization and formation of biofilm around the surface of the implanted device are prelude for clinical infection. Many antimicrobial agents, although may be effective against planktonic pathogens, have minimal or no effect against biofilm-embedded organisms. Thus, there is a pressing need to explore the approach of using compounds that can interfere with the biofilm that accommodates these pathogenic organisms. N-acetyl cysteine (NAC), a derivative of amino acid cysteine and a potent antioxidant, commonly used as a systemic remedy against toxicity with acetaminophen, is also used for inhalation therapy in patients with chronic bronchitis by breaking up the mucus. This mucolytic property may be a valuable tool in preventing the formation of biofilm or removing biofilms formed on medical devices. By elimination of the biofilm, antimicrobial agents become more effective against causative pathogens. Therefore, combination of NAC and an antibiotic may prove to be instrumental in combating catheter colonization and treating device-associated infection. In this proposal we plan to study the utilization of this combination to impregnate vascular catheters in order to prevent their bacterial colonization when implanted in patients. Furthermore, we would like to study the use this combination as a catheter lock solution to treat indwelling colonized catheters. PUBLIC HEALTH RELEVANCE: This project examines the possibility of using a combination of a chemical agent that breaks the network that pathogens can attach to when a medical device (i.e. catheter) is placed in a patient and an antimicrobial agent to prevent or treat infection of catheters. Although we will only experiment this model in the laboratory and with animals at this stage, this project mainly targets hospitalized patients who depend on intravenous means to receive drugs or nutrition.

Public health relevance
PI: Mansouri, M. D. Project Narrative This project examines the possibility of using a combination of a chemical agent that breaks the network that pathogens can attach to when a medical device (i.e. catheter) is placed in a patient and an antimicrobial agent to prevent or treat infection of catheters. Although we will only experiment this model in the laboratory and with animals at this stage, this project mainly targets hospitalized patients who depend on intravenous means to receive drugs or nutrition.